Role of altered response to volumetric distension in esophageal disease

PROJECT SUMMARY
Swallowing difficulties are extremely common and result in a substantial reduction in the quality of life
and increased morbidity and mortality related to malnutrition and complications related to regurgitation and
aspiration. Unfortunately, our understanding regarding the pathophysiology of dysphagia and GERD has been
hampered by focusing predominantly on circular muscle activity and ignoring the biomechanical properties of
the esophageal wall that promote normal emptying. Our initial work explored the relationship between intrabolus
pressure (IBP) and esophagogastric junction (EGJ) compliance as a metric for outflow resistance. This work
highlighted the direct relationship between IBP and EGJ opening and was the foundation for the development of
a new classification scheme for esophageal motor disorders, “the Chicago Classification.” Despite this improved
understanding focused on bolus transit dynamics, there are still significant unresolved issues centered on the
lack of a true correlate for symptoms or a predictive model for adverse outcomes. Given these limitations, we
have evolved our focus toward a more directed assessment of how wall distensibility and the response of the
esophageal body to volumetric distention will alter normal bolus transit. We hypothesize that the mechanical
properties of the esophageal wall will likely alter bolus transport by disturbing the normal low pressure state that
is required for asymptomatic bolus transit through the esophagus.
In order to test our hypothesis that wall mechanics are a major determinant of esophageal diseases, we
have had to develop new approaches and new technology to directly measure mechanical wall state. Using
impedance techniques combined with manometry, we are now capable of assessing IBP and diameter changes
across a space-time continuum (4D-IM). This approach will allow us to study the mechanics of bolus transport
beyond the isometric circular muscle contraction quantified by manometry and allow us to assess the ability of
the esophagus to accommodate the propagating bolus via isotonic relaxation and passive distention and the
ability of the esophagus to propel the bolus via passive recoil and auxotonic contraction. Additionally, we have
also modified FLIP techniques to assess the response of the esophageal wall to volumetric distention using
FLIP-panometry analysis. The response of the esophageal wall to bolus retention or reflux is one of the most
important functions of the esophagus in preventing complications of aspiration, reflux injury, or symptoms related
to bolus retention. We recently reported that the normal response to volumetric distention is associated with
repetitive antegrade contractions (RACs) and that this response was altered in specific disease states. Our
overarching goal will be to study well-defined patient populations before and after interventions targeting wall
distensibility to determine whether abnormalities in distensibility and response to volumetric distention are
important predictors of outcome. This work will build upon the previous success of the Chicago Classification
by defining new biomechanical biomarkers of disease activity and new targets for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Swallowing difficulties are extremely common and symptoms of dysphagia result in a substantial reduction in the quality of life for patients regardless of the cause. Unfortunately, our current understanding of the physiologic cause of these symptoms is limited by a lack of tools to accurately describe the mechanics of esophageal emptying. This proposal will utilize new analysis techniques to understand the cause of abnormal bolus transport and determine what can be done to improve esophageal function and quality of life.